Molecular tools for labeling and manipulating functional brain circuits

Project Summary
Molecular tools for labeling and manipulating functional brain circuits
A fundamental goal of neuroscience is to discover the subpopulations of neurons that are associated with specific
behaviors. For example, what neurons in the brain do we utilize when we experience fear, or thirst? What neurons are
utilized when we learn to associate a specific context or stimulus with the feeling of fear? The field has experienced a
revolution with the emergence of tools such as channelrhodopsins, DREADDS, real-time calcium indicators, and
multiphoton microscopes that enable monitoring and manipulation of neuronal activity in awake, behaving animals.
However, these tools are most useful when the experimentalist already has a specific hypothesis for which neuronal
subpopulations may be relevant to the behavior of interest. What is lacking is a technology to guide the researcher to
specific brain regions and neuronal subpopulations, when prior information about the behavior under study is absent or
incomplete.
Here we propose to develop a family of molecular tools, collectively called “FLARE”, for Fast Light- and
Activity-Regulated Expression, that may be highly useful for the study of the neural circuit basis of behaviors. FLARE is
a coincidence detector of light and elevated cytosolic calcium (a proxy for neuronal activity) that gives expression of any
reporter gene of choice as its output. If FLARE components are expressed throughout a brain region, and light is delivered
to that region via an implanted fiber, coincident with a stimulus of interest, then transgene expression should be
selectively turned on only in the subpopulation of neurons that fired during the moment of light delivery, which could be
as short as a few minutes to seconds. By using a transgene such as GFP-channelrhodopsin, it would be possible to both
image the neuronal subpopulation of interest, and drive its activity, thereby examining the causal relationship to behavior.
Our preliminary results show that second-generation FLARE2 marks activated neurons in culture with a tagging
time window of only 60 seconds. In this project, we propose to fully characterize and validate FLARE2 and its variants
(including single chain FLARE, scFLARE) in vivo (mouse and fly) while simultaneously applying protein engineering
techniques and directed evolution (with which our laboratory has extensive experience), to iteratively improve and
optimize the family of FLARE tools.
To permit brain-wide mapping of neural circuits, we also propose a FLARE variant, called “nanoFLARE”, that
can be uncaged by either light or a small-molecule that can be delivered throughout the entire brain via IP injection into
the animal. NanoFLARE features a luciferase moiety fused to the protease component of the tool, that we discovered can
uncage the light-sensitive LOV domain via proximity-dependent BRET. Hence, nanoFLARE can be uncaged either by
direct blue light illumination, or by delivery of the small-molecule luciferase substrate furimazine to the brain.
A successful outcome of this proposal would create a toolkit that will empower neuroscientists to discover neural
subpopulations that underlie a wide range of behaviors and cognitive processes, with unprecedented speed and accuracy,
and provide a means to interrogate the mechanisms by which these circuits encode function.

Public health relevance
Project Narrative Neurological and psychiatric disorders such as Alzheimer’s disease, autism, and schizophrenia cause enormous suffering and death, but may be the least understood and least treatable diseases across all of medicine. Here, we propose a bold and focused effort, grounded in rigorous biochemistry, protein engineering, and neurobiology, to develop a suite of molecular technologies that may help to elucidate the neural circuit basis of behaviors in both healthy and pathological states. Such understanding may yield insights that pave the way to new therapeutic approaches to these devastating neurological disorders.